Deciphering Novel Principles of Rapid Proteostatic Control and Innovating Spatiotemporal Lysosomal Tools

PROJECT ABSTRACT
Proteome integrity is maintained by a complex network that regulates protein synthesis, folding,
transport, and degradation. Lysosomes are the catabolic center of a cell and central to
maintaining proteome homeostasis by preventing, detecting, and removing abnormal proteins.
Major knowledge gaps remain in the regulation, structural components, and substrate
specificities of lysosomal substrates. Intracellular proteolysis through the ubiquitin-proteasome
system has been the most well-characterized eukaryotic proteolytic pathway as the protein
targeting by ubiquitin and the amino acid sequences recognized by E3 ubiquitin ligases are
well-defined. In contrast, a major obstacle in understanding lysosomal processes is the
incomplete knowledge of protein modifications that enable lysosomal trafficking mechanisms.
Our work identified that arginine methylation leads to protein delivery into lysosomes for
degradation. We showed that rapid methyl-driven delivery was essential for removing enzymes
from the cytosol to promote growth and proliferation. The proposed studies examine the central
hypothesis that methyl-driven lysosomal proteolysis is a widespread process that enables
natural protein turnover during homeostasis and rapid protein remodeling in response to
external stimuli. We address this hypothesis in three areas of research. Area 1 defines novel
protein substrates and the peptide motifs required for lysosomal delivery. Area 2 determines the
functional impact of rapid methyl-driven delivery as a control mechanism for fundamental
cellular metabolic pathways. Area 3 leverages naturally-occurring lysosomal protein signals to
develop tools for researchers to rapidly decrease protein levels in endogenous living systems.
We test the conceptually novel model that selective lysosomal proteolysis is central for
regulating cytosolic, short-lived proteins that were previously thought to be degraded in
proteasomes. We anticipate use of our publicly available database of novel methyl-degraded
lysosomal proteins will provide an essential resource for the fields studying protein control. We
develop technically innovative tools to gain new mechanistic insight into lysosomal biology for
the present studies while also providing a tool for the broader research community that
significantly improves current strategies for endogenous protein depletion.
11

Public health relevance
PROJECT NARRATIVE A common feature across all living organisms is the central goal to maintain homeostasis and as a result the cell devotes significant energy to the regulation of protein lifespan. Lysosomes are specialized compartments in every eukaryotic cell that are essential for protein breakdown, yet major gaps in knowledge remain in our understanding of the mechanisms underlying protein delivery and trafficking to lysosomes. The proposed research investigates the molecular pathways, enzymes, and regulatory factors by leveraging a new protein tag for lysosomal delivery, which could contribute a fundamental aspect of cellular homeostasis and for developing tools to control protein levels in biological research. 12